Leveraging high-throughput functional data for assessment of Alzheimer's risk

PROJECT SUMMARY
Alzheimer’s disease (AD) and AD-related dementias (ADRD) are irreversible, progressive brain disorders, and
AD in particular is the sixth leading cause of death in the United States. Neurological decline begins up to two
decades before cognitive symptoms are apparent in patients, highlighting the need for early risk assessment,
screening, and treatment. Given the high heritability of AD/ADRDs, genetic testing has the potential to inform
an individual’s risk. Although some common variants in APOE are known to modulate AD risk, the majority of
genetic risk stems from rare variants, which are collectively common in the population but individually have
little population data to support their classification. Thus, most variants in AD/ADRD risk variants are classified
as medically inactionable variants of uncertain significance (VUS), precluding identification and precision
management of high-risk individuals.
To address the need for improved clinical interpretation of AD/ADRD risk genes, Constantiam Biosciences is
developing MAVEvidence, an application that leverages recently-developed multiplexed assays of variant
effect (MAVEs). MAVEs probe disease-relevant functions of thousands of protein variants in a single
experiment and have proven useful for clinical interpretation of cardiovascular and cancer disease risk genes.
Recently, the first MAVEs for AD/ADRD genes generated data for thousands of variants of the AD risk gene
APP and the Lewy body dementia (LBD) risk gene SNCA. The data sets, however, are large and statistically
complex, requiring rigorous analysis before they can be applied as evidence, and are thus largely inaccessible
to clinical variant scientists. MAVEvidence brings several key innovations to the field of AD/ADRD gene variant
interpretation, including a rigorous statistical analysis of MAVE data within a Bayesian framework and
personalized, quantitative AD/ADRD risk assessment. MAVEvidence will be used by variant scientists at
genetic testing companies and diagnostic laboratories to classify variants that would otherwise be VUS, thus
enabling physicians and patients to make informed decisions about AD/ADRD screening and treatment.
This Phase I SBIR proposal focuses on developing MAVEvidence for use by variant scientists to interpret
variants in AD/ADRD risk genes. In Aim 1, we curate and validate data from all three published MAVEs for
APP and one for SNCA. In Aim 2, we calibrate the odds of pathogenicity for each variant based on scores of
known pathogenic and benign variants and then translate these odds to functional evidence that can be
applied directly within existing variant interpretation frameworks. In Aim 3, we generate personalized
quantitative measures of risk based on genotype by integrating MAVE data and population AD/ADRD
incidence data with the goal of validating our model using biobank data. Successful completion of these aims
will de-risk a planned Phase II focused on application to a broader set of AD/ADRD risk genes and
development of a commercial-ready product.

Public health relevance
PROJECT NARRATIVE Genetic testing holds great promise for early assessment of risk for Alzheimer’s disease (AD) and AD-related dementias (ADRD), empowering patients and clinicians to make informed decisions about screening, treatment, and long-term care. Nevertheless, the clinical impact of testing is limited by the challenge of interpreting rare genetic variants, which are collectively common in the population and account for the majority of genetic AD/ADRD risk. Constantiam Biosciences is developing MAVEvidence, an application that leverages Multiplexed Assays of Variant Effect (MAVEs) as functional evidence to interpret gene variants in AD/ADRD risk genes, enabling clinical geneticists to access curated, analyzed, and validated MAVE data and to assess a patient’s personalized risk of disease.